Examining the Impact of Local Policies on Sociodemographic Disparities in Tobacco Use

PROJECT SUMMARY/ABSTRACT
The goal of this proposed study is to examine the impact of retail policies on disparities in
tobacco outcomes and allow me to establish research independence as an early-stage
investigator. The tobacco retail environment greatly influences tobacco use disparities through
the presence of advertisements, promotions, and the availability of tobacco products.
Communities with predominantly lower socioeconomic and minority population groups have
more tobacco retail stores and higher tobacco prevalence, hence perpetuating tobacco use
disparities. To curb the effect of the retail environment on tobacco use, localities are actively
adopting policies that limit tobacco product availability. Some policies include restrictions on the
sale of flavored tobacco products (FTP) or tobacco retailer licensing (TRL) policies to reduce the
presence of tobacco retail stores. However, the impact of these policies on selected tobacco
outcomes or related disparities remains understudied and unclear. This policy evaluation study
will use advanced statistical methods to achieve three main goals: 1) describe and examine the
impact of local TRL laws and fees on sociodemographic differences in retailer density by area-
level race/ethnicity, income, and education; 2) explain and measure the impact of local FTP
restrictions on sociodemographic differences in product sales within the communities by area-
level race/ethnicity, income, and education; and 3) visualize and investigate the interactive
effect of both policies on sociodemographic differences in individual-level exclusive and dual
youth and adult cigarette and e-cigarette use. This K01 Mentored Career Development Award
will provide the necessary foundation for my career as a principal investigator, skilled in
analyzing tobacco policies with advanced analytic skills to understand their effect on tobacco
outcomes and health disparities within the communities. These study findings will help
policymakers and researchers understand the need to revise existing or adopt new retail
policies to address the tobacco use epidemic in their communities.

Public health relevance
PROJECT NARRATIVE Despite the proliferation of local retail policies to curb tobacco use, the impact of these policies on disparities in tobacco outcomes remains unclear. This evaluation study, which uses advanced statistical methods has three primary goals: 1) describe and examine the impact of local TRL laws and fees on sociodemographic differences in retailer density by area-level race/ethnicity, income, and education; 2) explain and measure the impact of local FTP restrictions on sociodemographic differences in product sales within the communities by area- level race/ethnicity, income, and education; and 3) visualize and investigate the interactive effect of both policies on sociodemographic differences in individual-level exclusive and dual youth and adult cigarette and e-cigarette use using spatial and causal inference modeling. These study findings provide insight into future directions for tobacco retail policymaking to help curb the tobacco epidemic within the communities.